PRELIMINARY STUDIES OF C-13-HIOLEIN AND C13-NEOLATE AS PROBES FOR FA METABOLISM

The purpose of this study is to attempt to develop a practical, fat breath test to detect malabsorption of fat in patients.